PIMAGEDINE IN PATIENT WITH TYPE II DIABETES AND OVERT DIABETIC NEPHROPATHY

The primary objective of this study is to evaluate the safety and efficacy of pimagedine in preserving renal function in patients with non-insulin dependent diabetes and overt diabetic nephropathy.